Biomarker discovery in colon cancer through next-generation metabolomics

PROJECT SUMMARY
Metabolomics is the study of small molecule metabolites and has drastically improved health research,
diagnostics, and patient treatment. Metabolomic approaches quantify the abundance of small molecules within
biological samples using liquid chromatography coupled to mass spectrometry (LC/MS), which is capable of
simultaneous detection of 1,000s of metabolites. Cancer, a fundamentally metabolic disease, has benefitted
greatly from metabolomics, having enabled the discovery of tumor heterogeneity, novel biomarkers, and
individualized treatments. Until recently, however, nearly all large-scale metabolomics analyses have been
limited to targeted studies of a few hundred pre-discovered metabolites. In part, this is due to the data burden
and uncertainty in global analysis of all detected metabolites (i.e., untargeted metabolomics). Researchers have
been slow to adopt untargeted metabolomics because it relies heavily on software to evaluate the large number
of signals detected. Unfortunately, current software are limited by two major factors: (1) ~90% of the detected
signals do not represent unique metabolites but are false positives or redundant compound detections derived
from chemical or electronic noise that current software does not address, and (2) More than 80% of measured
metabolites are removed from downstream analysis due to ambiguous identifications, in large part due to
software programs not providing statistical scores for metabolite identification certainty. These limitations lead to
an inflated data burden, poor metabolome coverage, and misidentified metabolites, diminishing the value and
impact of untargeted metabolomics to cancer research. At Panome Bio, we are the first metabolomics CRO to
bring a truly untargeted metabolomics approach to biomedical researchers. Our company currently offers
untargeted metabolomics in a fee-for-service model and has achieved strong initial traction, completing >100
customer projects to date. An important aspect to this platform is MassID, our Next-Generation untargeted
metabolomics analysis software. While effective, our current version of MassID (MassID 1.0) is designed to focus
only on the most confidently identified metabolites at the expense of removing ambiguous (but informative) data.
Here, we propose to develop two software components that will improve the scoring and filtering systems used
during metabolite identification: PeakDefrag and DecoID2. These will be integrated into a second-generation
analysis software (MassID 2.0) that is hosted on the cloud and available through a web application, offering all
researchers straightforward access to their data. The grant will be completed by benchmarking MassID 2.0
against MassID 1.0 and other untargeted software approaches in a colon cancer cohort. With these results, we
plan to be the first metabolomics company to back metabolite identifications with statistical values and to further
our position as the leading platform in eliminating the number of signals derived from noise. We expect Mass ID
2.0 to transform untargeted methods by increasing the number of statistically significant metabolite identifications
and to advance Panome Bio as an industry leader in multi-omics discovery research, a market valued at $750M.

Public health relevance
PROJECT NARRATIVE In the field of metabolomics, where metabolites in a biological sample are profiled, there is immense potential to improve health research, diagnostics, and patient treatment. Current metabolomics approaches are severely limited by the lack of adequate analysis software that can process the thousands of signals generated in metabolomics experiments. This application supports the creation, validation, and demonstration of MassID 2.0, an analysis software that will be integrated within the full metabolomic service pipeline already commercialized by Panome Bio to transform the field of metabolomics and enhance searches for novel biomarkers, drug targets, and biological insights in diseases like cancer.